Emory Alzheimer's Disease Research Center

SUMMARY/ABSTRACT: RESEARCH EDUCATION COMPONENT
Alzheimer’s disease (AD) is the most common cause of dementia, affecting more than 5 million Americans. At
the same time that the prevalence of AD is increasing, the number of new investigators in the US is
decreasing, which may severely hamper our efforts to develop better diagnostic and treatment tools for AD and
related dementias (ADRD). The goal of the Research Education Component (REC) of the Goizueta
Alzheimer’s Disease Research Center (ADRC) at Emory is to support research educational activities that
complement and enhance the training of the future workforce to meet the nation’s biomedical, behavioral and
clinical needs in ADRD. We will achieve this goal by identifying and supporting the research education of junior
investigators and trainees from diverse backgrounds and disciplines. In Aim 1, REC leadership and mentors
will work with these trainees to develop and execute tailored educational plans for new and early stage
investigators to advance towards independence in conducting AD-related research. In Aim 2, we will leverage
Emory’s wealth of basic and clinical scientists as well as partner Atlanta-area institutions to identify, recruit and
support the research training of new/early stage investigators and trainees from diverse backgrounds and
disciplines, with special emphasis on URMs, to engage in AD-related research. In Aim 3, the REC leadership
and external advisory committee will rigorously monitor and evaluate the trainees, mentors, and the overall
program, and implement improvements when necessary. Success of the REC will result in rolling cohorts of
new investigators with a focus on diversity to lead the next generation of ADRD research.

Public health relevance
Per RFA-AG-20-004 Project Narrative: Do not complete. Note: ASSIST screens will show an asterisk for this attachment indicating it is required. However, eRA systems only enforce this requirement in the Overall component and applications will not receive an error if omitted in other components.